BREAST PROSTHESES FOR SUBRADICAL SURGERY

The objective in the development of protheses for subradical surgery and radiation therapy cosmesis. The first task involves the manufacture of hardware to fabricate devices using vacuum molding methods. A series of experiments using adult rabbits will be used to: 1) evaluate the performance and safety of the percutaneous filling port used to adjust the volume of the implanted devices, and 2) to characterize the effects of volume adjustments on tissue capsule structure.